Randomized Trial of a Targeted Palliative Care Intervention for Patients with Metastatic Breast Cancer

Project Summary/Abstract
End-of-life care (EOL) for patients with metastatic breast cancer (MBC) is markedly inadequate, as evidenced
by this population’s low rates of hospice service use and increased likelihood of receiving chemotherapy and
dying in the hospital at the end of life compared to those with other types of solid tumors. Studies show that
integrating palliative and oncology care for patients with serious cancers improves patient-clinician communica-
tion about EOL care preferences and subsequent delivery of EOL care. However, for those with MBC, many of
whom have long disease trajectories, integrating outpatient palliative care from the time of diagnosis is neither
scalable nor clinically indicated. Furthermore, prospective studies evaluating interventions to improve EOL out-
comes specifically for patients with MBC are lacking. To address this evidence gap, we developed and success-
fully pilot-tested a five-session palliative care intervention called TARGET-PC, specifically for patients with MBC
who had clinical indicators of poor prognosis per manual chart review. TARGET-PC significantly improved EOL
care communication and delivery in this population, though identifying the subgroup of patients with MBC at risk
of death within 12 months remains a challenge. For the next step in this program of research, we now propose
to utilize the Epic End-of-Life Care Index (EOLCI), a validated and scalable regression-based prediction model,
to prospectively identify this vulnerable cohort and demonstrate the efficacy of TARGET-PC in a large-scale
multi-site trial for patients with poor-prognosis MBC and their family caregivers. The aims of the study are to
improve the documentation of patients’ EOL care preferences, delivery of EOL care, and participant-reported
outcome measures. Using the Epic EOLCI, we will identify and enroll 400 patients with MBC at risk of death
within 12 months and their family caregivers across three academic cancer centers (i.e., Massachusetts General
Hospital Cancer Center, Penn Abramson Cancer Center, and Duke Cancer Center). Participants will be ran-
domly assigned to receive either the five-session TARGET-PC intervention or to an enhanced usual care control
group that involves an electronic health record prompt sent to oncology clinicians encouraging them to discuss
and document their patients’ EOL care preferences. Natural language processing methods will be used to query
the electronic health record to collect data regarding discussion and documentation of patients’ EOL care pref-
erences and hospice utilization. Participants will also complete self-report measures of quality of life, mood
symptoms, coping strategies, and communication about EOL care preferences at baseline prior to randomization
and then again at weeks 12, 24, 36, and 48. The proposed intervention trial not only aligns with national priorities
to improve the quality of EOL care for patients with advanced cancer but also leverages advances in innovative
technology (i.e., Epic EOLCI and natural language processing) to overcome prior limitations in identifying at-risk
study cohorts and potential biases in assessing key EOL care outcomes via the electronic health record. This
study will lay the groundwork for delivering scalable, timely, and personalized palliative care services for patients
with long disease trajectories.

Public health relevance
Project Narrative Patients with metastatic breast cancer who are approaching the end of life often experience high symptom bur- den and acute hospitalizations without sufficient communication with care teams about their end-of-life care wishes or the support of palliative or hospice services. The purpose of this multi-site trial is to test the efficacy of a targeted, five-session palliative care intervention designed specifically for those with poor-prognosis metastatic breast cancer and their caregivers in order to improve communication with clinicians and the quality of end-of- life care. This study will lay the groundwork for ultimately delivering scalable, timely, and tailored palliative care interventions for patients with advanced cancer who have long disease trajectories.